Long-acting formulations of griseofulvin for ocular neovascularization therapy

Neovascularization in the retina or choroid of the eye is a key feature of major causes of blindness such as
neovascular age-related macular degeneration and proliferative diabetic retinopathy. Anti-vascular endothelial
growth factor biologics have greatly aided treatment, but resistance to therapy, side effects, frequent intravitreal
injections, and high cost remain significant limitations, creating a critical need for new therapy. Previous research
revealed an appealing new target for the development of such therapies: the heme synthesis enzyme
ferrochelatase (FECH), which, when inhibited or genetically modified, blocks neovascularization. The approved
anti-fungal drug griseofulvin is naturally metabolized in vivo to form a FECH inhibitor. Griseofulvin thus blocks
angiogenesis in vitro and in retinal and choroidal neovascularization animal models, offering promise for
“repurposing” this old drug for ocular neovascularization treatment. However, griseofulvin has not been optimized
for ocular use. For griseofulvin to be competitive with existing therapeutic modalities, it must be made available
in a long-acting formulation for intravitreal use. Preliminary data reveal that griseofulvin can be formulated into
polymeric implants and polymeric microparticles, which are amenable to sustained release over at least two
months and effective against laser-induced choroidal neovascularization (L-CNV) weeks after application. Given
this feasibility, the long-term goal is to provide a safe and affordable alternative to existing biologic agents by
developing long-acting griseofulvin systems. The hypothesis is that long-term griseofulvin delivery can prevent
ocular neovascularization. The hypothesis is based on prior research supporting FECH as an effective
antiangiogenic target and griseofulvin as an indirect inhibitor of FECH. Polymeric implants and particles are well-
received, long-term ocular drug delivery systems. With combined expertise in formulation, drug delivery, and
neovascular eye disease, and preliminary results supporting controlled griseofulvin release, the team is poised
to develop long-acting griseofulvin systems as new local therapies via three specific aims: 1. To optimize release
kinetics of griseofulvin-encapsulated polymeric microparticles and implants. Poly(lactic-co-glycolic acid)
microparticles and hot melt extruded polymeric implants will be developed to achieve 2-12 month delivery and
characterized biophysically and in vitro. 2. To evaluate griseofulvin microparticles for antiangiogenic effects.
Optimized microparticle formulations will be tested for long-term drug release in vivo, toxicity, efficacy, and target
engagement in the L-CNV and Vldlr-/- subretinal neovascularization mouse models. 3. To evaluate griseofulvin-
releasing polymeric implants for antiangiogenic effects. The optimized implant formulation will be tested for long-
term drug release in vivo, toxicity, and efficacy in the DL-aminoadipic acid rabbit retinal neovascularization
model. The core innovation of this strategy is the repurposing of griseofulvin for ocular neovascularization
therapy by creation of sustained release formulations. If successful, these formulations would inhibit the
progression of neovascularization with minimum inconvenience to the patients and cost to the healthcare system.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because our new polymer devices enable safe, affordable, effective, and convenient therapy of neovascular eye diseases such as neovascular age-related macular degeneration and proliferative diabetic retinopathy, which cause irreversible blindness in millions of patients. Therefore, this research is consistent with the mission of the NIH, which pertains to developing resources that will assure the nation's capability to efficiently prevent and/or treat human diseases.